AIM2 Function in Beta Cells and Type 1 Diabetes

SUMMARY/ABSTRACT Type 1 diabetes (T1D) is an autoimmune disease characterized by the destruction of the insulin producing β cells. The diabetogenic response is complex influenced by genetic and environmental factors, which promote the breakdown of peripheral immunoregulation. Ill-defined properties intrinsic to β cells are also believed to play a key role in T1D. β cell reactivity to autoimmune and environmental insults, growth factors and nutrients for instance, influence loss of β cell mass and/or function. Defining the pathways and mechanisms regulating these β cell responses is important for the development of effective T1D immunotherapies and β cell replacement approaches such as islet transplantation. This R21 application is based on our novel observation that NOD mice deficient in the AIM2 inflammasome molecule remain diabetes-free. AIM2 is a cytoplasmic immune sensor that is typically associated with host defense. Upon binding double stranded DNA from a microbial pathogen, AIM2 drives assembly of an inflammasome complex leading to production of proinflammatory IL-1β and IL-18 as well as pyroptosis- mediated cell death. Recent studies, however, have demonstrated that AIM2 can serve a regulatory function outside of host defense via a nonconical pathway that is independent of inflammasome activation. We find that the lack of diabetes in AIM2-deficient NOD mice is also independent of inflammasome activation. Furthermore, evidence suggests that AIM2 deficiency reduces β cell sensitivity to autoimmune- mediated destruction while enhancing β cell replication and function. We hypothesize that AIM2 functions as a “thermostat” regulating the strength of responses to stress- and growth-inducing factors that impact β cell survival, expansion and/or function. The overall goal of this proposal is 2-fold: 1) establish that AIM2 function is intrinsic to β cells and affects T1D progression, and 2) begin to define the role of AIM2 in regulating β cell reactivity to immunological insults and homeostasis. With this in mind, Specific Aim 1 will determine if AIM2 directly regulates β cell sensitivity to cytokine and cell-contact-driven destruction, and in turn the development of overt diabetes in NOD mice. Experiments will include testing if an AIM2 variant expressed by NOD mice enhances β cell destruction. Specific Aim 2 will define a role for AIM2 in β cell homeostasis. Here we will determine if AIM2 regulates signaling events that stimulate β cell replication. Together this work will establish a novel regulatory pathway in which AIM2 controls β cell sensitivity to various immune stressors and factors that impact β cell loss and function, and T1D progression. These findings will set the stage for future efforts to further define mechanisms by which AIM2 regulates β cell reactivity, as well as exploit AIM2 for the purpose of T1D immunotherapy and β cell replacement.

Public health relevance
NARRATIVE The goal of this work is to define the role of the AIM2 inflammasome molecule in regulating β cell homeostasis and sensitivity to autoimmune insults, in the context of type 1 diabetes. The proposal will establish a new pathway to further dissect the immunobiology of β cells. Targeting the AIM2 pathway may also provide a strategy to enhance the efficacy of immunotherapy, islet transplantation and other β cell replacement strategies.